Rosie the Chatbot: Leveraging Automated and Personalized Health Information Communication to Reduce Disparities in Maternal and Child Health

PROJECT ABSTRACT/SUMMARY
Stark racial/ethnic disparities are prevalent for infant mortality and birthing people mortality and
morbidity due to the interacting effects of systemic racism, homophobia, and transphobia that hinder protective
social determinants of health and barriers to affordable, high-quality, culturally competent, and affirming
prenatal and postnatal healthcare. The Rosie project has the potential to alter the way health information is
presented to vulnerable populations. Currently, some popular programs involve resource-intensive home visits
(limited in scale due to staff and cost constraints) or non-personalized text messages (may not directly address
an individual's questions). We developed Rosie the chatbot that addresses both of these possible limitations by
representing a scalable tool that can have widespread reach across geographies and is personalized and
responsive to an individual's specific informational needs. Our Parent Grant Specific Aims are: 1) Develop
technology for a chatbot, Rosie, that will provide health informational support to vulnerable mothers the
moment they need it; 2) Evaluate the use of Rosie on maternal and infant outcomes; and 3) Release an open-
source packet for the construction of a chatbot. This supplement proposes extensions of the Rosie software to
serve diverse sexual and gender minority (SGM) communities. Supplemental aims include: 1) Enable Rosie to
serve diverse sexual and gender minority (SGM) communities, and 2) Explore the feasibility and acceptability
of Rosie to serve diverse sexual and gender minority (SGM) communities. The supplemental activities extend
the potential impact of the Rosie mobile app by making the software resource more responsive to the needs of
SGM pregnant and new parents of color, accessible, interactive, and adaptable to the different needs of users,
community organizations, and health researchers. Furthermore, the Rosie software importantly removes
technical barriers associated with obtaining and constructing a chatbot that can be adapted to a variety of
communities and health needs.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO PUBLIC HEALTH Infants and birthing people from communities of color experience the highest rates of mortality and morbidity in the United States due to the interacting effects of systemic racism, further exacerbated among sexual and gender minority (SGM) parents of color by stress due being part of a multiply marginalized community. Whereas popular programs for minoritized populations involve resource-intensive home visits or non- personalized health information materials, we propose extensions of the Rosie the chatbot software that addresses both possible limitations by representing a scalable tool that can have widespread reach across geographies and is personalized and responsive to an individual's specific informational needs. Results from our project can be utilized to inform system-wide and local strategies to reduce health disparities by lower barriers to access to timely and verified health information.